A diagnostic biomarker for amyotrophic lateral sclerosis

Amyotrophic Lateral Sclerosis (ALS), a fatal adult onset motor neuron disease characterized by selective
loss of upper and lower motor neurons, and Fronto-Temporal Dementia (FTD), a common form of dementia
characterized by a progressive deterioration in behaviour, personality and/or language, share a common disease
spectrum. The neuropathology involving Transactivation response element DNA-binding protein 43 (TDP-43)
occurs in nearly all cases of ALS and large proportion of FTD, neurodegenerative diseases currently without
effective therapy. The overarching goals of this proposal are to develop a diagnostic test for ALS. By developing
monoclonal antibodies designed to recognize cryptic exon encode peptides, we show that loss of TDP-43
splicing repression occurs in pre-symptomatic C9ORF72 patients. This novel finding would support the idea that
loss of TDP-43 function occurs during early stage of disease. In this application, we will establish this important
mechanistic insight and develop a diagnostic test for prodromal phase of ALS, a critical unmet need in the field
relevant for recruitment of patients at their earliest stage of disease and for monitoring target engagement in
clinical trials. Proposed studies in this application will have important implications for developing a diagnostic test
for the prodromal phase of ALS.

Public health relevance
The discovery of loss of TDP-43 splicing repression occurring during early stage of disease in Amyotrophic Lateral Sclerosis (ALS) provided the opportunity to develop a diagnostic biomarker to monitor the loss of such function during the prodromal phase of ALS. Such diagnostic test will impact on future therapies designed to complement loss of this TDP-43 function for this illness, which currently is without effective treatment.